Applying Community-Engaged Intervention Mapping Methods to Improve Transitional Care in Aphasia Rehabilitation

PROJECT SUMMARY/ABSTRACT
This K23 career development award will position the candidate to become an independent clinical researcher
with expertise developing and testing transitional interventions in aphasia rehabilitation to improve care
delivery and long-term outcomes for individuals with communication disabilities. BACKGROUND. Aphasia is a
debilitating, chronic impairment in language expression and/or comprehension with devastating impacts on
societal participation, psychosocial well-being and overall health and quality of life. Inadequate discharge
coordination and fragmented rehabilitation care further contribute to poor outcomes for people with aphasia.
Current healthcare processes are structured to provide rehabilitation care around acute episodes of injury,
rather than delivery coordinated services for individuals with chronic conditions. There is an urgent need to
improve care delivery to support people with aphasia as they transition along the rehabilitation continuum.
Transitional care interventions that include patient-family education, communication and coordination across
health professionals and actions for care continuity have been shown to improve care quality and outcomes in
the management of chronic medical conditions. The objective of the current proposal is to develop and test a
transitional care intervention to improve communication and quality of life outcomes for people with aphasia.
SPECIFIC AIMS. Guided by the Intervention Mapping Framework and community-engaged research methods,
the proposed studies will (1) evaluate current practices, needs and barriers and facilitators in transitional care
in aphasia rehabilitation, (2) develop/refine and (3) test the feasibility, acceptability, and preliminary efficacy the
aphasia-specific transitional care intervention. TRAINING. The candidate will achieve short-term goals through
a research-rich institutional environment and a comprehensive training plan in (1) the synthesis of advanced
qualitative and multi-methods research, (2) development and adaptation of complex interventions, and (3)
clinical and implementation measurement for trial design. In addition to mentorship meetings and experiential
training through the research plan, the candidate will complete targeted coursework, present at local and
national conferences and publish in peer-reviewed journals. MENTORSHIP. The candidate will be supported
by an exceptional, interprofessional mentoring team: Leora Cherney, PhD, CCC-SLP (co-primary mentor),
Janet Prvu Bettger, ScD (co-primary mentor), Jeffrey Schneider, MD (co-mentor) and Ruth Palan Lopez, PhD
(co-mentor). IMPACT. In line with NIDCD’s funding priorities, this work will yield a robust, clinically feasible
transitional care intervention for aphasia care and inform a future R01 proposal to conduct a fully powered
efficacy trial. Through this K23 award, the candidate will develop the necessary skills and training to
successfully transition as a leader and independent investigator focused on translational and health systems
research to improve outcomes for people with aphasia and other communication disabilities.

Public health relevance
PROJECT NARRATIVE Current rehabilitation care delivery models fail to address the long-term communication needs of people with post-stroke aphasia, who experience poorer health and quality of life outcomes than their peers without communication disabilities. At present, there is a critical gap in the evidence in how to structure rehabilitation care to deliver the right care, at the right time and in the right manner to optimize long-term outcomes for people with aphasia. The primary objective of the proposed study is to develop and test a transitional care intervention for aphasia rehabilitation that improves communication and quality of life outcomes for people with aphasia and their families.